Cytoskeleton, Nucleus and Integrin Recycling in Cell Migration

SUMMARY
Metazoan cell migration contributes to developmental and homeostatic processes, including formation of tissues and
organs, wound healing, tissue renewal and immune responses. Alterations in cell migration lead to developmental defects,
inflammation, persistent wounds and metastasis. Deciphering mechanisms of cell migration thus has broad significance
for understanding both physiological and pathological processes. Considerable effort has led to deep understanding of
some of the critical processes that contribute to cell migration, including protrusion of the leading edge and formation of
adhesions. Other important aspects of cell migration have received scant attention and there is a gap in our understanding
of their mechanism and contribution to cell migration. This proposal seeks to fill this knowledge gap for two such
processes: nuclear positioning and integrin recycling. Both these processes are essential for cell migration, but mechanistic
understanding of how they do so is lacking. This proposal will build on results previously obtained in two previous projects
in the Gundersen laboratory supported by NIGMS. For nuclear positioning, we will examine how the linker of
nucleoskeleton and cytoskeleton (LINC) complex is mechanically reinforced to resist the large forces necessary to move
the nucleus and will use and develop new tension sensors to directly measure forces on the nucleus. We will determine
how the LINC complex selects actin filament or microtubules for nuclear movement and the functional consequences of
these interactions for different modes of cell migration. We will test new hypotheses that the nucleus functions as a
“tension resistor” for actin filaments and as a polarity factor for microtubule trafficking. For integrin recycling, we will test
the overall hypothesis that recycled integrins travel in an active conformation and that this seeds new adhesion formation
in a polarized manner near the leading edge. We will use new integrin probes and a new integrin recycling system to
identify sites of integrin exocytosis and their relationship to newly formed adhesions. In migrating cells, we will determine
whether recycled integrin derives from the cell rear and contributes to nascent adhesion formation near the leading edge.
We will identify the microtubule machinery that we hypothesize is responsible for the polarized reformation of adhesions
from recycled integrins and test the possibility that the recycled integrin plays a role in integrin signaling. Our proposed
studies on these two processes will advance understanding of the basic mechanisms of cell migration and potential
identify new targets for intervening in cases when cell migration goes awry. The proposed studies will also provide fertile
ground for postdoctoral fellows and graduate students to advance their training and develop their own projects.

Public health relevance
PROJECT NARRATIVE Cell migration is a fundamental property of most cells and contributes to development, wound healing, immune responses and a host of other processes. This project focuses on two poorly understood processes in cell migration: nuclear positioning and endocytic recycling of integrin adhesion receptors. Deciphering the contribution of these processes to cell migration will provide new basic information to understand cell migration and may help identify new strategies for intervention in cases where cell migration becomes unregulated, such as cancer metastasis and inflammation.